Architecture, dynamics and cell-specific behavior of tau condensates

Abstract/Project Summary
The ultimate goal of this proposal is to understand the molecular and cellular substrates of early tau
pathology, in order to create the foundation for future therapeutic targets for Alzheimer’s Disease
(AD) and Alzheimer’s Disease Related Dementias (ADRD). Tau is a protein, expressed in neurons and
oligodendroglial cells, whose aggregation is a pathological hallmark of a wide range of neurodegenerative
diseases, including Fronto-Temporal-Dementia (FTD). Mounting evidence shows that the pathogenic
process begins long before the detection of neuronal aggregates, with the detection of white matter changes
in subjects with mild cognitive impairment, although the underlying pathogenic processes responsible for
these changes remain only partially understood. This proposal will directly address this major gap of
knowledge in the field, and tackle the major research priority of the 2019 NIH ADRD Summit, to
investigate the early events of the disease.
We leverage the expertise of the PI in biochemistry and phase separation and that of the co-I in myelin
biology, to test the hypothesis that the white matter changes detected at the early stages of ADRD are
mediated by misregulation of the condensed state of tau in oligodendrocytes. This hypothesis is
motivated by the evidence that: 1) tau can self-assemble into a novel phase-separated condensed state
(“condensate”); 2) tau mutations specific for FTD specifically impact tau condensates and 3) that
oligodendroglial lineage cells, the myelin-forming cells of the central nervous system, are specific sites of
tau-mediated dysfunction at the early stages of the neurodegenerative process. Extensive evidence in human
subjects and animal models of FTD identify myelin damage and oligodendroglial dysfunction at the earliest
stages of cognitive decline and support a model of neurodegeneration consequent to myelin pathology and
occurring long before the detection of aggregates.
Here we take an interdisciplinary biophysical and cellular approach that leverages expertise in tau
biochemistry and glial biology, in order to test this hypothesis. In aim1 we will develop quantitative
metrics for defining tau condensates – a crucial advance necessary for understanding how tau condensates
are modulated. In aim 2 we will determine the influence of tau pathological variants and myelin protein
and lipids on tau condensate properties. In aim 3 we shall examine the role of endogenously expressed
and exogenously uptaken tau and tau variants in oligodendrocyte lineage cells at specific stages of
differentiation.
Together, results from this work will illuminate the role of tau condensates in oligodendrocytes and further
our knowledge of the events occurring at the early stages of tau pathology.

Public health relevance
Project Narrative This proposal addresses the mechanisms underlying the early events of Alzheimer’s disease and related dementias by using oligodendrocyte biology-inspired and rigorous biophysical approaches to the study of tau condensates.